CLASSIFICATION TREE (CART) SOFTWARE FOR CANCER STUDIES

Our goals are to provide enhancements to Classification and Regression Tree (CART) software and to create SAS and SYSTAT interfaces on multiple platforms. Enhancements include: (1) a complete Graphical User Interface; (2) a tree-editor for direct visual manipulation of tree-structures including modification of split criteria, and manual pruning and grafting; (3) interactive application of any statistical procedure, including summary statistics procedures, regression, non-linear modelling and high resolution graphics, to the cases passing through a given node; (4) summaries of the copious output of cross-validations to assist users in refining tree-structured analyses, particularly when initial results yield no tree or very shallow trees with low predictive power; (5) addition of Breiman's within-node error measure; (6) incorporation of Boolean splits (and/or combinations of individual splitting rules) into the library of potential splitting rules; (7) extension of the CART algorithms to apply to censored survival data; (8) performance enhancements for single CPU machines and porting CART to run on parallel processing multiple CPU platforms; (9) improving the portability of the source code for different hardware platforms; and finally, (10) the provision of tutorial materials to assist researchers in applying the methodology.